Admin-Core

SUMMARY - ADMINISTRATIVE CORE
The Administrative Core of the Massachusetts Partnership for Community-Engaged Cancer Control
Equity (Mass PCECCE is designed to provide scientific and administrative leadership and governance to
ensure an integrated and sustained focus on our aims. Co-led by an academic (Emmons) and a community-
based (Clark) MPI, the Core is designed to provide strong and inclusive governance, articulate our scientific
vision and theme, coordinate collaborative activities across the Center and relevant partnership resources, and
advance the Center's theme through administrative support and continuous evaluation of our activities. The
Administrative Core will play a critical role in ensuring that the proposed Center achieves its goals and that it is
connected to the broader research and community health fields to maximize impact. The Core will also ensure
that our work is well-connected with the U19 consortium and that we work well with the Coordinating Center.
We have strategically designed the Administrative Core to oversee our capacity-building activities, with a
Capacity-Building Team to support aims related to building effective teams to address SDOH. This effort is
designed to harness the abilities held by members of the communities most affected by structural harms. Our
capacity-building efforts focus on: (1) catalyzing academic-community partnerships focused on SDOH; (2)
building the capacity of research teams to build coalitions and use community organizing and agenda-setting
strategies as part of transformative interventions; and (3) engaging graduate students from backgrounds that
are under-represented in science to co-lead capacity-building efforts.
To achieve our goal of creating a community-partnered approach to research and capacity building to address
key SDOH facing partner communities, we will: (1) develop a strong operational structure that integrates
activities across the Center as well as community and academic partner assets; (2) monitor and evaluate our
efforts to build an effective coalition that is committed to addressing SDOH; and (3) actively participate in
cross-Consortium activities to enhance learning locally and nationally.
We have integrated community partner engagement into every aspect of Mass PCECCE, drawing on core
principles of community-engaged research. Every Core or project is co-led by an academic and a community
partner. We have ensured that there is balanced representation on all governance structures and review
processes, and our budget reflects a commitment to shared resources. Most importantly, Mass PCECCE is
built on the foundation of a 5-year collaboration that has borne deep respect and commitment to the shared
work, which will bring significant benefit to the proposed collaboration.